Pilot Study of Standardized PatiEnt-CenTered medicatiOn Review (SPECTORx) in Home Hospice

PROJECT SUMMARY/ABSTRACT A tremendous challenge in home hospice care is ensuring that medication prescribing is appropriately aligned to patients’ goals of care and that medications are appropriately managed by family caregivers. Therefore, we propose a novel intervention that trains hospice staff to 1. regularly review, simplify, and align patients’ prescribed medications with their goals of care as their illness progresses, and 2. support family caregivers with education that empowers them to understand each medication’s use, develop skills for safe administration, and understand when stopping medications may be beneficial. This program is called Standardized PatiEnt- CenTered medicatiOn Review (SPECTORx) in Home Hospice, and is based on a combination of 3 existing, complementary, educational programs that, together, train hospice staff to create a comprehensive, patient-centered, medication management care plan. The program also creates an online learning community that promotes ongoing education and practice change for hospice clinicians. This R21 pilot study aims to demonstrate the feasibility of conducting a clinical trial to evaluate the efficacy of SPECTORx. The long-term objective is to test the hypothesis that SPECTORx reduces inappropriate medication prescribing and improves family caregiver reported quality of care. However, to accomplish this, we must first address challenging questions regarding the design, feasibility, and execution of trials in home hospice. We will accomplish this using a stakeholder engagement process to refine the SPECTORx intervention and trial protocol. We will then conduct a pilot cluster randomized trial and compare outcomes within and across 2 large, multi-office, hospice agencies from Utah and Massachusetts. Within each hospice agency, we will randomize 1 office to intervention and 1 office to attention control. Target enrollment is n=60 family caregiver-patient dyads of patients aged ≥65 years with advanced, life-limiting illness. Primary outcomes are acceptability and feasibility of the SPECTORx intervention by hospice stakeholders, and acceptability, burden and completion of family caregiver assessments (Family Caregiver Medication Administration Hassle Scale at baseline, 2 weeks, 4 weeks, 12 weeks, and quarterly). The overarching goal of this research is to align patient’s prescribed medications with their goals of care at each stage of their advanced illness and to support family caregivers’ medication management challenges. Ultimately, we want to improve the quality of medication prescribing, reduce treatment complexity and medication-related harm, and improve family caregiver outcomes for the almost 600,000 million elderly Americans who receive home hospice services annually.

Public health relevance
PROJECT NARRATIVE/PUBLIC HEALTH IMPORTANCE Over 1.3 million Americans aged 65 years and older receive hospice services annually and 45% are cared for at home. Most are prescribed 10-12 medications daily on average, many of which are of questionable benefit and are potentially harmful. To improve medication use in this frail and vulnerable population, we propose a novel approach that trains hospice staff to 1. regularly review, simplify, and align patients’ prescribed medications with their goals of care as their illness progresses and 2. support hospice family caregivers with education that empowers them to understand each medication’s use, develop skills for safe administration, and understand when stopping medications may be beneficial.